Computational Exploration of Plant Natural Products Bioactivity and Bioavailability in Human Health

Natural products, par�cularly those derived from plants, are some of the most widely used
small-molecule drugs today, with over half of all drugs approved in the past four decades
naturally derived or closely related to natural products. This project uses computa�onal
approaches to model nanoscale interac�ons between natural products from plants, fungi, or
bacteria and their environment to facilitate use and eﬀec�veness for natural products in human
health and disease contexts. To this end, we have developed a molecular simula�on campaign
to quan�fy the ligand-protein and ligand-membrane interac�ons fundamental to natural
product u�liza�on and extrac�on. Since the natural product landscape is so broad, our focus is
directed towards exis�ng compounds where we have exis�ng collabora�ons. For lignin, a
polyaroma�c polymer found in plant cell walls, we are measuring binding to human hormone
receptors to evaluate its poten�al as a replacement plas�cizer in industrial applica�ons.
Cisprenyltransferase and the long polyisoprenoid chains it synthesizes oﬀer a unique look at
how natural product synthesis is controlled, even if the ligand does not ﬁt inside the protein
ac�ve site. Similarly, iden�fying a mitochondrial target for sorgoleone, a compound excreted in
large quan��es by sorghum roots, would open new avenues to probe and alter metabolism in
mitochondria. Other calcula�ons explore the membrane permeability of speciﬁc natural
products used to treat cancer, such as vinblas�ne or taxol, across mul�ple membrane
composi�ons to elucidate if membrane permeability changes between cell types drive
diﬀeren�al eﬃcacy of cancer treatments. A further systema�c treatment of membrane
permeability in mul�component membrane models could pave the way for connec�ng modern
lipidomics and transport kine�cs for small molecules. The simula�ons involved in this research
use advanced sampling techniques like Hamiltonian replica exchange umbrella sampling (REUS),
or free energy perturba�on (FEP) already used extensively in the PI laboratory to measure
quan��es such as binding aﬃni�es, free energy proﬁles across biological membranes, and other
measures cri�cal to the biophysics of natural products in vivo.

Public health relevance
Plants, fungi, and bacteria create many natural products with health impacts, such as an�bio�cs, cancer treatments, and metabolic regulators. By conduc�ng molecular simula�ons to model natural products enter and leave cells, and quan�fy binding for these small molecules to the appropriate interac�on partner, we can make these natural products more eﬀec�ve and available at lower cost.